ACTG 223--SAFETY AND EFFICACY OF THREE CLARITHROMYCIN CONTAINING DRUGS

ACTG 223 (v2.0): This phase II/III prospective, multicenter, randomized, controlled trial will compare the safety and efficacy of three clarithromycin-containing combination drug regimens for the treatment of disseminated mycobacterium avium complex (MAC) disease in persons with AIDS.